Genomic basis of variation in the transcriptional response to pathogens among primates

PROJECT SUMMARY
An organism’s response to environmental perturbations is a complex process that is influenced by the
interplay between genetic and environmental factors. However, despite playing a critical role in health and
survival, the gene-by-environment interactions (GxE) shaping disease susceptibility remain poorly understood.
Understanding the genomic mechanisms underlying GxE is therefore essential for understanding the
consequences of genetic variation on genomic function and complex traits.
The immune response to infectious agents is a GxE interaction with clear consequences for health and
survival. Mounting an appropriate immune response is essential, but substantial genetic variation in immune
function exists within and between species. This makes immune responses an ideal system to understand how
genetic and environmental variation interact to shape genome function. Specifically, comparative studies
leveraging genetic variation within and between species can help reveal the genomic mechanisms for GxE, while
also shedding light on the molecular basis for differences in susceptibility to infectious disease.
The research questions driving this proposal are: How does genetic variation, both within and between
primate species, influence the gene expression response to immunological perturbations? What are the gene
regulatory mechanisms that mediate the relationship between gene expression and genetic variation? Which
genetic variants are causally connected to variation in the gene expression response? To answer these
questions, I will characterize the transcriptomic response to immune stimuli in peripheral blood cells using a
powerful, in vitro assay and single-cell sequencing. This project will identify GxE interactions that are cell type,
stimuli, and species-specific. I will then profile chromatin accessibility to identify key regulatory elements involved
in the response to immune perturbation and use experimental assays to causally link genetic variation to
differences in the response. This project is therefore an ambitious, novel integration of functional and
population genetic approaches to study how the genome responds to environmental perturbations. At
its conclusion, this study will reveal how immune GxE interactions have evolved among primates, improving our
understanding of genome function and the genetic basis for complex traits.

Public health relevance
PROJECT NARRATIVE Appropriately responding to environmental perturbations is key to proper genome function, but how genetic variation affects these responses is poorly understood. This project uses comparative genomic approaches to understand the gene regulatory mechanisms underlying variation in the response to immune stimulation (a well understood environmental perturbation) among humans and other primates. The results will yield a detailed molecular understanding of gene-by-environment interactions across cell types, conditions, and species, providing insight into the mechanisms shaping complex traits, genome function, and human health.